Parmodulins without Abuse Potential for the Treatment of Neuropathic Pain

PROJECT SUMMARY
Neuropathic pain, a chronic condition from nerve damage frequently caused by physical injury, diabetes, or
chemotherapy, is a debilitating situation that affects up to 10% of people worldwide. Current therapies are
helpful but clearly inadequate; 17% of people in one survey described their neuropathic pain as “worse than
death”. New classes of medicines for neuropathies are urgently needed, especially those lacking abuse
potential and without onerous side effects.
Evidence has accumulated pointing to inflammatory signaling driven by extracellular proteases as a driver of
pain and neurodegenerative processes. The critical coagulation enzyme thrombin, and other proteases such
as matrix metalloproteinases, have been connected to neuroinflammation and/or neurodegeneration in certain
models. Direct inhibition of thrombin and other extracellular proteases is possible but frequently problematic,
due to their pleiotropic effects on numerous targets. Alternatively, one can modulate these pathways by
targeting certain membrane proteins, typically GPCRs or integrins, acting as their receptors. We have identified
and characterized a new class of small molecules, called parmodulins, that allosterically modify the signaling of
a receptor for thrombin, protease-activated receptor 1 (PAR1). In this manner, parmodulins can bias PAR1
signaling from a pro-inflammatory to an anti-inflammatory cyto- and barrier-protective phenotype, in a manner
analogous to the action of the anti-inflammatory activated protein C (APC), which also acts at PAR1.
This project will investigate the use of parmodulins for the treatment of neuropathic pain from physical injury,
and will test in part the hypothesis that neuropathic pain is associated with permeability of the blood-spinal cord
barrier. In Aims 1 and 2, a range of novel parmodulins will be synthesized and tested for PAR1 activity,
selectivity, and maintenance of endothelial barriers, using assays developed in our labs. Drug-like properties
(including solubility and stability) will be measured for active compounds, and optimal examples will undergo
rodent pharmacokinetic studies to measure bioavailability and other parameters, to determine their potential for
chronic oral dosing. Several representative parmodulins will progress to Aim 3, where they will be tested for
analgesic effects in a rat spared nerve injury model. Sensitivity to pressure and heat will be measured using
standard protocols, and potential behavioural impairments from novel compounds will be measured. Blood-
spinal cord barrier integrity will be determined by dosing with Evans Blue and measuring extravasation to the
lumbar spinal cord. The lack of abuse potential of the parmodulin class of anti-inflammatories will be confirmed
with a self-administration study in rats. Promising results in these proof-of-concept studies will justify the
preclinical development of parmodulins for the treatment of neuropathic pain from physical injury, and
potentially other neurodegenerative disorders.

Public health relevance
PROJECT NARRATIVE Neuropathic pain is a chronic condition caused by injury to parts of either the central or peripheral nervous system, and is characterized by abnormal sensations or heightened, painful sensitivity to stimuli. It affects millions of Americans, and current therapies have limited efficacy or have severe side effects. This project will develop and investigate a subset of parmodulins, a new class of orally active antithrombotic and anti- inflammatory molecules, and test them in rodent models of neuropathic pain, behavioral impairment, and abuse potential.